Biomimetic approaches for enthesis tissue engineering

ABSTRACT
Rotator cuff tears are prevalent, particularly in the elderly population, and typically require surgical repair to
regain shoulder function. Unfortunately, successful repair remains a major clinical challenge, with high post-
operative failure rates. At the root of these failures is poor healing at the repaired tendon-to-bone interface, which
does not regenerate the native tendon enthesis attachment structures. Specifically, the healthy tendon enthesis
consists of a transitional tissue with spatial gradations in composition (e.g., mineral content) and cell phenotype
(e.g., tenocytes, chondrocytes, and osteoblasts), which provides a strong and tough attachment to transfer
muscle load from tendon to bone. To address the critical clinical need to improve outcomes after tendon-to-bone
repair, this project brings together a multidisciplinary research team to develop, validate, and translate a novel
class of biomimetic scaffolds for enhancing healing. The team is led by Dr. Thomopoulos (MPI, an expert in
tendon-to-bone development, pathology, and repair) from Orthopedics and Biomedical Engineering at Columbia
University and Dr. Xia (MPI, an expert in materials science and nanotechnology) from Biomedical Engineering
at Georgia Tech. Key compositional and structural features of the natural tendon-to-bone attachment will be
directly fabricated in Aim 1 or generated by stem cells provided with the appropriate cues in Aim 2. The first
(acellular) approach has the benefit of high throughput and off-the-shelf availability whereas the second (cellular)
approach has the advantage of a responsive extracellular matrix generating component. Funnel-shaped
microchannels will be laser drilled through the depth of the scaffolds to encourage cell migration and extracellular
matrix deposition, and thus alleviate the concern that the interposed scaffold will be a barrier to healing between
the tendon and bone. These two designs will be independently fabricated and evaluated in vitro and then tested
in a clinically relevant animal model of rotator cuff injury and repair in Aim 3. Reducing the failure rates of rotator
cuff surgical repairs will have a major impact on a large population of patients. The proposed clinically relevant
translational studies have the potential to directly impact the treatment of rotator cuff injuries. Furthermore, the
results will be broadly applicable to connective tissue-to-bone repair in other locations (e.g., ACL reconstruction,
meniscal repair).

Public health relevance
NARRATIVE Surgical repair of tendon to bone is a long-standing clinical challenge. The high failure rates after rotator cuff repair are due to a lack of regeneration of the native functionally graded enthesis connecting tendon and bone. The aim of this project is to develop and validate a novel class of stem cell-seeded biomimetic scaffolds to regenerate the enthesis after rotator cuff repair.